Navigating Financial and Health-Related Social Needs in Adolescent and Young Adult Cancer Survivors (AYA-NAV): A Digital Intervention Pilot Study

Adolescent and young adult (AYA) cancer survivors represent a growing population due to recent advances in
cancer treatment. AYA survivors, defined by the National Cancer Institute as aged 15-39 years, experience a
high burden of chronic health conditions, and they face devastating financial toxicity, defined as the negative
personal financial impact of healthcare costs. Financial toxicity results not only from the cost of care, but also
from unmet health-related social needs (HRSN: food insecurity, un/underinsurance, unstable housing,
suboptimal education, and unemployment). Historically minoritized AYAs (Black, Hispanic/Latino, poverty-
exposed AYAs) disproportionately experience adverse social determinants of health that are associated with
poorer health outcomes. We are currently testing an adapted adult model of financial navigation intervention
for Spanish and English-speaking AYAs with cancer who screen positive for financial toxicity or unmet HRSN.
As in the adult model, our intervention is delivered in partnership with a nonprofit organization that provides
telephone-based case management and needs navigation to people with life-limiting illnesses. In our study,
AYAs are interested and consent to participate, however, uptake and sustained engagement with the
intervention model are rarely observed. We now propose to refine our current, low-technology model to a
digital platform and add vocational navigation to better engage AYAs and address their unmet HRSN.
Findhelp.org is an established, digital network of local resources, such as community organizations, that
provide specific support to address HRSN (e.g., insurance navigation, transportation, SNAP benefit support).
Further, our clinical vocational liaison team are established and able to conduct standardized consultations and
referrals to address vocational needs. We will used iterative co-design focus group sessions to refine our
needs navigation model (AYA-NAV) to address these needs (Aim 1) and then, conduct a pilot randomized trial
among 80 AYAs with financial toxicity or unmet HRSN, to evaluate the feasibility of AYA-NAV (Aim 2), and
explore the preliminary impact of AYA-NAV delivered over 6 months on AYA financial and global health
outcomes, compared to enhanced usual care (one-time referral to findhelp.org) (Aim 3). To achieve the aims of
this study, we will use a mixed-methods approach and leverage our study team, expert advisors, and
consultants representing AYAs, caregivers, clinicians, community partners, and human-centered design
evaluation. This study is in alignment with the National Institute of Nursing Research’s strategic goals to
advance health equity and to reduce disparities among individuals experiencing adverse determinants of
health. We have an outstanding team of experts with expertise in nursing science, medicine, AYA psychology
and oncology, health outcome disparities, human-centered design, cancer care delivery, and mixed methods,
and thus, we are uniquely positioned for success. Our line of research has the potential to address critical
understudied inequities in care delivery, improving quality of life and health outcomes for AYAs with cancer.

Public health relevance
PROJECT NARRATIVE The overall goal of this mixed methods study is first, to refine our current model of financial and health-related social needs navigation to integrate an established digital platform of community resources and to optimize our vocational navigation support (Aim 1). Then, we will evaluate the feasibility, including AYA uptake and engagement (Aim 2) and explore the preliminary impact on reducing financial toxicity and improving global health outcomes (Aim 3) among 80 racially, ethnically, and socioeconomically diverse AYA cancer survivors in New York City. Our intervention is patient-informed, leverages clinical and community partnerships, and thus has a high likelihood of success as well as sustainability, scalability, and overall impact.